The role of lipid droplet proteins in eicosanoid production and non-alcoholic fatty liver disease

SUMMARY/ABSTRACT
1 Current estimates indicate that ~30 % of the global adult population is affected by non-alcoholic fatty liver disease
2 (NAFLD). NAFLD is associated with an increased risk of morbidity and mortality from hepatic and extra-hepatic
3 complications, such as cardiovascular disease. Recent research has identified hepatic lipid droplets (LDs) as
4 important players in NAFLD, yet their exact role in the pathogenesis and progression of this disease is not fully
5 understood. One of the key functions of hepatic LDs is to store polyunsaturated fatty acids (PUFAs) and regulate
6 the availability of arachidonic acid (AA). Recent evidence has shown that plasma levels of PUFAs and
7 eicosanoids are associated with NAFLD severity and cardiovascular disease. However, the role of LD proteins
8 in regulating PUFA metabolism and liver inflammation has not been investigated. To address this gap, the
9 principal investigator (PI) will study common genetic coding variants in two LD proteins that may alter PUFA and
10 eicosanoid metabolism and, thus, affect NAFLD progression. The first is PNPLA3-I148M which is well-known as
11 a risk factor for NAFLD and associated comorbidities. The second is PLIN2-Pro251 which has been recently
12 shown to be associated with a reduction in hepatic triglycerides in a NAFLD mouse model. The hypotheses at
13 the heart of this project are that PNPLA3-I148M augments the release of AA from the LD membrane, increasing
14 eicosanoid production, liver inflammation and NAFLD progression, whereas PLIN2-Pro251 decreases the
15 release of AA from the LD membrane, thereby reducing eicosanoid production, liver inflammation and NAFLD
16 progression. Using a genome-first approach, in the K99 phase, the PI will conduct a `recall-by-genotype' study
17 to deep phenotype subjects who are PNPLA3-I148M homozygous without liver disease, and matched controls
18 (Aim 1); in parallel, the PI will use human-derived induced pluripotent stem cells (iPSCs) differentiated to
19 hepatocyte-like cells (HLCs) to determine the role of PNPLA3-I148M on eicosanoids metabolism and LD biology
20 (Aim 2). In the R00 phase, the PI will turn her attention to PLIN2-Pro251. Further embracing a `human phenomic
21 science' approach, she will deep-phenotype subjects homozygous for PLIN2-Pro251 without liver disease, and
22 matched controls (Aim 3) and study the role of this genetic variant in eicosanoid production, VLDL secretion and
23 LD biology in human-derived HLCs (Aim 4). The PI will learn the necessary techniques to accomplish the
24 proposed research under the guidance of her mentors (Dr Rader and Dr FitzGerald) and Advisory Committee.
25 Her training will include 1) becoming proficient in designing and conducting deep phenotyping studies involving
26 genetic variants, and 2) mastering the use of iPSCs as tools to recapitulate metabolic variations observed in the
27 population. The PI will also gain a better understanding of mass spectrometry, bioinformatics, extracellular
28 vesicles, and flow cytometry techniques by working alongside specialist collaborators. Combining these new
29 skills with her prior expertise in LD metabolism, hepatic inflammation and NAFLD, will enable the PI to develop
30 a `big-picture' systems biology perspective, an invaluable asset in her future role leading her own research team.

Public health relevance
Narrative Non-alcoholic fatty liver disease (NAFLD) affects ~30% of the global adult population and is associated with morbidity and mortality from hepatic and extra-hepatic complications, causing a major health burden for our society. Hepatic lipid droplets (LDs) have emerged as important players in NAFLD, yet their impact on its pathogenesis and progression is not fully understood. By studying common genetic coding variants in two LD proteins (PNPLA3-I148M and PLIN2-Pro251), this proposal aims to elucidate the role of LDs in NAFLD, leading to a better understanding of this disease and providing new therapeutic targets.